ANALYSIS OF BRAIN IMAGE DATA

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We propose to use the facilities at PSC to support our research to study the brain activity that encodes the meanings of words and phrases in the human brain. Our approach involves developing a computational model that predicts the brain activity observed via fMRI when a person reads arbitrary nouns. The model is trained using statistics of word use collected from a trillion-token text corpus, together with gigabytes of fMRI data. It is both computationally intensive and data intensive, making the PSC facilities an excellent platform for our computational needs.